Development of SMART on FHIR interoperable clinical decision support for emergency department patients with pneumonia and pilot deployment into novel Epic electronic health record environments

Project Summary
In the United States, more than 1.5 million adults are hospitalized each year with community-acquired
pneumonia. Despite availability of high-quality guidelines for the treatment of patients with pneumonia,
guideline adherence remains poor and patient care is variable. Lack of objective risk assessment leads to
unnecessary hospital admissions and misallocation of scarce intensive care resources. Thus, there is a
critical need for well-designed clinical decision support (CDS) tools to assist clinicians with accurate
diagnosis and appropriate treatment for patients with pneumonia. Intermountain Healthcare developed
and deployed real-time electronic CDS (called ePNa) embedded in the Cerner electronic health record
(EHR) across 20 adult hospital emergency departments. ePNa gathers real- time and historical data from
the EHR combined with artificial intelligence processing of chest images (ChexED) to guide pneumonia
diagnosis, risk stratification, site of care, risk of antibiotic resistance, and treatment. ePNa smooths
transitions of care between clinicians. Our work incorporates the Five Rights of CDS to optimize the
technology’s strengths in the clinical environment. Two controlled studies demonstrate that ePNa
increases guideline-recommended, best practice care and decreases 30-day all-cause mortality in adults
with pneumonia. ePNa is ready to be deployed to additional environments with distinct patient
populations and EHRs. However, siloed EHRs limit technology developed within one vendor from being
shared with others. The objective of this proposal is to enable broad dissemination of ePNa by
optimizing its interoperability, scalability, and usability. Accordingly, we aim to (1) Develop a SMART on
FHIR ePNa application capable of interfacing with both the Cerner and Epic EMRs and conduct a
formative evaluation through an iterative design process. We will rapidly refine and validate the new
ePNa application. (2) Engage patients and clinicians to inform the patient-centeredness of ePNa’s clinical
interface. The project will incorporate feedback from stakeholder clinicians, administrators, and patients
to understand contextual factors affecting implementation success in a novel geographic and
demographic environment. (3) Evaluate the feasibility and acceptability of ePNa through a pilot
implementation trial guided by the RE-AIM QuEST framework.
Our proposal is likely to facilitate guideline adherent care for patients with pneumonia broadly across
different healthcare systems.

Public health relevance
Project Narrative Community-acquired pneumonia is the most common serious infection among adults in the United States, but diagnosis and treatment decisions by clinicians fall short of consistent, guideline-adherent care, thereby threatening patient safety. We aim to disseminate a validated real-time, electronic clinical decision support tool for pneumonia and optimize its interoperability, scalability, and usability by developing a SMART on Fast Healthcare Interoperability Resources version that places patients and clinicians at the center. We will then deploy the tool to two distinct emergency departments at Vanderbilt, study the implementation process, and evaluate the impact on patient outcomes.